2023 NASDA Annual Meeting

PROJECT SUMMARY/ABSTRACT
The objective of NASDA’s 2023 Annual Meeting is to provide information on current and emerging feed
and food safety issues impacting agriculture, and to build consensus among the states on regulatory
approaches to these issues. The plenary speakers will give state regulators an opportunity to hear a
national perspective on feed and food safety, something to which they may not be exposed in their
respective states.
NASDA has two membership meetings a year. One is the annual meeting in the state of the current
president; the other is the Winter Policy Conference held in the Washington, DC area. The focus of the
meetings is legislative and regulatory issues of interest to the members. These two occasions and one
additional meeting, held regionally, are the opportunities for NASDA members to converse on issues,
make contacts with each other and other leaders, set priorities and goals for the coming year and meet
face-to-face with NASDA staff and FDA officials.
At recent meetings, NASDA members have stressed the fact that there must be continuous efforts made
on the part of FDA and NASDA members to collaborate and cooperate in discussions on emerging FDA
topics that directly and indirectly affect agriculture. The states and FDA share similar authorities,
missions and responsibilities, and the partners have been working to improve communications. The
passage of the Food Safety and Modernization Act has created a plethora of issues to be discussed and
resolved as we seek to establish an integrated federal-state food and feed safety system. The need for
conversation about not only the policies entailed in implementation of FSMA and the rules but also the
importance of developing strategies that work for FDA and the state partners cannot be overstated.
The 2023 Annual Meeting presents the opportunity for NASDA members, NASDA staff, and key FDA
leaders to interact with each other, focusing on feed and food safety and regulatory issues, and
promoting partnerships to ensure program success.
The Annual Meeting is three days long, and the agenda includes committee meetings, plenary sessions,
focus sessions, and speakers. NASDA has a Food Safety and Nutrition Committee that meets during this
time to discuss topics focusing on FDA program areas in which state programs interact. In addition,
NASDA generally has a private meeting between NASDA food safety leadership and the key FDA leaders
in attendance. NASDA Members and key FDA leadership also find time during the meeting for mini-
conferences on issues of interest and concern.
The conference will be held in Cheyenne, WY. The number of participants is anticipated to be
approximately 400 people in person and an additional 100 watching the virtual live stream. Meeting
attendees consist of NASDA members and their staff, NASDA staff, representatives of state and federal
regulatory agencies charged with feed and food safety responsibilities, the regulated industries, and
university and research institution professionals.

Public health relevance
Public Health Relevance Statement The objective of NASDA’s 2023 Annual Meeting is to provide information on current and emerging feed and food safety issues impacting agriculture and to build consensus among the states on regulatory approaches to these issues. The plenary speakers will give state regulators an opportunity to hear a national perspective on feed and food safety, enhancing attendees’ exposure beyond the current events they are dealing with in their respective states. The private meeting between FDA senior leaders and NASDA members provides an opportunity for frank conversation and progress to be made in developing a consistent, integrated food safety system to meet our collective public health goals. NASDA members and staff work with FDA programs and leadership to ensure that consumers have a safe feed and food supply; 45 NASDA member agencies have cooperative agreements to implement the Produce Safety Rule; 47 state departments of agriculture have feed control authority and over half of them are performing preventive controls inspections under the Food Safety and Modernization Act (FSMA); approximately 20 state departments of agriculture have manufactured food authority and cooperate with FDA in the administration of these laws and rules. NASDA has collaborated with FDA on major outbreak announcements. Many NASDA member agencies also cooperate with FDA on food safety for milk and seafood. NASDA staff frequently posts FDA press releases in the weekly NASDA News e-newsletter and many NASDA members’ agencies link to FDA’s recall lists. NASDA staff also serve on the Executive Committee of the Produce Safety Alliance and NASDA has 2 cooperative agreements with FDA, one for produce safety and the other for animal food safety, to assist FDA and the states to implement FSMA rules.